A cell-permeable peptide therapeutic to reduce myocardial reperfusion injury

PROJECT SUMMARY
The most deadly type of heart attack, ST-segment elevation myocardial infarction (STEMI)
involves blockage of the coronary artery and affects approximately 750,000 people annually in
the US. While percutaneous coronary intervention (PCI) saves lives by restoring blood flow to the
ischemic heart, as much as half of the long-term damage to the heart is due to the reperfusion
injury, for which there is no approved therapeutic shown to significantly reduce resulting cardiac
infarct size. Larger infarcts are strongly associated with reinfarction, hospitalization with heart
failure, and all-cause mortality. In the proposed Phase I SBIR Small Business Transition grant,
Laborecom Therapeutics Inc. is developing a novel therapeutic peptide to reduce reperfusion
injury. While other therapeutics have attempted to reduce reperfusion injury by direct immune
suppression or reduction in mitochondrial stress, this approach targets a motor protein uniquely
expressed in endothelial cells to prevent transendothelial migration. In aim 1, the therapeutic
peptide will be optimized for stability, permeability, and plasma protein binding while maintaining
therapeutic activity as measured by in vitro transendothelial migration assay. In aim 2, optimized
peptides will be tested head-to-head in a mouse model of myocardial infarction for their ability to
impact heart function as measured by echocardiogram and limit infarct size as measured by
histopathology. The successful completion of these aims will result in an optimized lead candidate
for further development through a Phase II award including IND-enabling studies and testing in a
swine model of myocardial infarction. In addition to scientific research, under this transition award
Laborecom Therapeutics will support the career development of Dr. Lucas Shores through a
tailored career development plan. This will include entrepreneurial training through local and
national programs, as well as direct mentorship from serial entrepreneurs and current executives
at biotechnology companies to facilitate his transition to a career as an entrepreneur and
independent investigator.

Public health relevance
PROJECT NARRATIVE There are no therapeutics approved for myocardial reperfusion injury which is responsible for up to half of the long-term damage to the heart after myocardial infarction and percutaneous coronary intervention (PCI). Successful development of the proposed peptide therapeutic will drastically improve outcomes for patients receiving PCI, improving patient quality-of-life while reducing rates of re-infarction, rehospitalization, and heart failure.